Micromanipulator systems, TransferMan 4r and FemtoJet 4i

Abstract
In the parent grant, we plan to learn the state-of-the-art micromanipulation system in Dr. Marko's lab at
Northwestern University and then set up our own one at the University of Illinois, Urbana-Champaign. By using
the micromanipulation system in Marko's lab, we have obtained many interesting data on meiotic chromosomes
and published one paper in Communications Biology. In addition, we are the first group who isolated metaphase
I spindle with chromosomes in mouse oocytes. This will provide novel approaches to study chromosome
segregation and abnormality. Our findings on inter-chromosomal interaction will also establish a new paradigm
on chromosome segregation.
My local co-investigator, Dr. Leckband, has a similar micromanipulation system at the University of Illinois,
Urbana-Champaign. However, this system lacks automatic micromanipulators. Without the two manipulators, it
is impossible to capture the meiotic chromosomes and further measure their biophysical properties. After setting
up the system locally, more members from my lab can be trained to use the cutting-edge technology, which is
essential for the success of these proposed projects.
We recently found that the measurement of meiotic chromosomes from mutant spermatocytes and oocytes could
not be conducted in Dr. Marko's lab because fresh mutant testes and ovaries are required. The mutant
spermatocytes became unhealthy after the shipment from Urbana to Evanston. However, all the mutant mouse
lines are currently maintained at the University of Illinois, Urbana-Champaign. This means we have to use a local
micromanipulation system to measure the stiffness of the chromosomes from the mutant spermatocytes and
oocytes. The data collected from these mutants is fundamental for the proposed projects.
In summary, we are the first group to apply the micromanipulation system onto meiotic chromosomes. Thus, the
local system will be vital for completion of the proposed projects, dramatically speed up these projects, and
facilitate intriguing discoveries.

Public health relevance
Narrative The purpose of this proposal is to receive support to purchase two micromanipulators and their accessory equipment, which will allow us to build a local micromanipulation system as proposed in the parent grant. This will greatly facilitate the proposed projects and provide more exciting novel findings on meiotic chromosomes via micromanipulation.